IGF::CL::IGF: THIS SERVICE IS FOR MEETING PLANNING, ADMINISTRATION AND TRAVEL REIMBURSEMENT.

This order is being entered to request travel services, signage, and folder materials for the 2018 Clinical Trials Methodology and Outcome Measures for FTD Meeting, being held at the Marriott Metro Center, Washington DC from March 08-09, 2018.